Novel Sensor Integrated Proteome on Chip (SPOC) platform for evaluating kinetic parameters of protein interactions in high throughput

Abstract
A critical bottleneck in the field of proteomics is the inability to simultaneously and cost-effectively
evaluate thousands of functional protein interactions at once to obtain kinetic data. Although
conventional in-situ protein microarray technology is well developed, it uses fluorescent dye
based detection that provides only qualitative or semi-quantitative information. There is currently
no technology that offers label-free real-time interaction assays of full-length folded proteins in
high throughput format. To address this unmet need, INanoBio is developing novel sensor
integrated proteome on chip (SPOC) platform that combines in situ expression and capture of
functional proteins on biosensors, to allow instant high throughput analysis of thousands of
proteins in real time. In this SBIR phase II project, we propose to develop SPOC platform by
integrating in situ produced protein arrays with surface plasmon resonance imaging (SPRi), by
building integrated ProSPR instrument that will enable SPRi determination of both qualitative and
kinetic information of protein biomolecular interactions in high throughput. We will develop,
validate and apply 1000 protein SPOC SPRi sensor chips to study clinically relevant protein-
protein interactions and test off-target binding of new antibodies produced in animal models
against human proteins.

Public health relevance
Project Narrative Protein binding and interactions with other proteins, DNA/RNA, metabolites and other biomolecules drive biological functionality at the molecular level. Currently there are no tools for real time sensing of protein interactions in high throughput with thousands of proteins at once. The proposed project aims to develop a novel sensor integrated proteome on chip platform to produce and analyze thousands of in-situ expressed functional proteins onto SPRi (surface plasmon resonance imaging) biosensor chips, with the end goal of addressing unmet needs in proteomic research from novel antibody validation, serum screening, biomarker discovery, and drug and vaccine development.